Pathophysiology of Myocardial Disease

PROJECT SUMMARY/ABSTRACT
Cardiovascular disease continues to be a dominant cause of morbidity and mortality in the
United States and throughout the world. While many gains have been achieved in some areas,
the epidemic of obesity, diabetes, and life-style risk factors is contributing to expanding
prevalence of heart failure. The advances made over the past decade have resulted from the
dedication and talents of many researchers in basic, translational, clinical, and population
epidemiological scientific inquiry. For nearly 45 years, The Johns Hopkins T32 Program in
Cardiovascular Disease has trained many of these researchers, and with this renewal proposal
we aim to continue this success. Our philosophy is to provide a broad-based, multi- and inter-
disciplinary research environment with which to train post-doctoral fellows in basic, translational,
clinical, and/or population science. Our program accepts physicians in Cardiology - some with
PhDs as well who are dedicated to pursuing an academic research career, as well as non-
clinical trainees (PhD or MD) pursuing cardiovascular science. This mixture of basic and clinical
scientists has fostered an unusual environment conducive to out-of-the-box thinking and
translation of novel approaches to new understandings and treatment of cardiovascular disease.
While centered in the Division of Cardiology, the program engages faculty throughout the Johns
Hopkins Medical Institutions with expertise and interest in cardiovascular research. This
includes faculty in Divisions/Departments of Pulmonary Medicine, Pediatrics, Epidemiology,
Pathology, Biomedical Engineering, Computer Science, and Genetic Medicine. All have long-
standing collaborations with Cardiology Division faculty. The primary areas of research covered
in our program encompass basic science in ventricular and vascular pathobiology, pulmonary
hypertension; regenerative cell biology and tissue engineering; immunology and metabolism;
computational modeling, and bioinformatics including artificial intelligence and deep learning.
Clinical and translational research focuses on heart failure, electrophysiology, cardiovascular
imaging, and interventional cardiology. Large population studies focus on epidemiological
studies and health care delivery. The program supports 12 positions for generally 2 years of
research training. It also includes two positions with a structured year of formal course work to
provide a master’s degree or certificate program in clinical investigation, epidemiology or public
health. With this renewal, we continue our primary goal of providing leadership in academic
cardiology, training future leaders in all levels of research to help combat cardiovascular disease.

Public health relevance
PROJECT NARRATIVE Heart and vascular disease is a leading cause of disability and death in the United States. The Johns Hopkins Cardiology Post-doctoral Training Program, now in its 44th consecutive year, provides broad multi-disciplinary training spanning from basic science up through to population/outcomes research. Our goal is to train the next generation of academic cardiovascular research leaders to continue the work of tackling these important and common diseases.